University of Washington (UW) Sexually Transmitted Infections (STI) Cooperative Research Center (CRC) - Syphilis Vaccine to Protect against Local and Disseminated T. pallidum Infection

PROJECT SUMMARY
Syphilis has been a scourge on humanity for hundreds of years. It has been impossible to
eradicate due to biological and societal barriers. Despite curative therapy and multiple public
health campaigns to eliminate syphilis in the US, the incidence is rising in diverse groups: men
who have sex with men, women, and children. An effective syphilis vaccine will be a key tool in
the eradication of this disease. Prior efforts to create a protective syphilis vaccine focused on
raising antibodies against rare outer membrane proteins to facilitate antibody mediated
opsonophagocytosis of Treponema pallidum (Tp) in infectious lesions. These vaccines only
generate partial protection in the rabbit model and have not advanced to human trials. Notably,
these candidate antigens did not specifically target T cell responses. We believe that better
understanding of T cell specificity and phenotype will provide insights into novel strategies to
design an effective syphilis vaccine. For example, the inclusion of immunodominant T cell
antigens in a subunit vaccine can provide CD4 T cell help to B cells to produce opsonic
antibodies. At this time, there are no reported human Tp T cell antigens validated to the epitope
level. Aim 1 focuses on identifying immunodominant CD4 T cell antigens. We will use rare cell
enrichment to measure, sort and then expand Tp-specific CD4 T cells. We will expand our
extant panel of recombinant proteins to probe CD4 T cells, determine which Tp protein antigens
are recognized, and follow up antigen-level hits to the peptide epitope level. Less is known
about the CD8 response during syphilis. While T. pallidum is canonically extracellular and as
such not expected to elicit a classic peptide-specific CD8 T cell response, we know that there
are abundant CD8-expressing cells within active syphilis lesions. We don't know if they are
responding to Tp peptide epitopes, or if they are classic or innate-spectrum lymphocytes. Aim 2
focuses on better understanding the CD8 response. Multicolor immunohistochemistry will
determine if these CD8-expressing cells are classic T cells with hypervariable TCRs, or cells
such as NK, NKT, MAIT, or gamma-delta T cells. Their phenotype will guide future studies
towards determination of the Tp-associated molecules recognized by these cells. Overall,
knowledge of Tp T cell antigens will significantly improve our ability to design the next-
generation candidate vaccines against syphilis.

Public health relevance
PROJECT NARRATIVE The incidence of adult and congenital syphilis continues to rise in the US and vaccines will be integral in ending this epidemic. The findings in this study will extend the Aims of the UW STI CRC U19 Project 3 to identify additional candidate subunit syphilis vaccine antigens and to understand the local immune response in syphilis skin lesions.